Developmental Trajectories of Sleep EEG Biomarkers and Risk of Psychopathology Through Young Adulthood

Project Summary
The brain undergoes anatomical and physiological changes with the onset of puberty, of which synaptic pruning
and increased myelination in a posterior-to-anterior gradient are hallmarks. These neural changes are reflected
in the sleep electroencephalogram (EEG), with sleep intensity and depth sharply declining and sleep integrity
plateauing during adolescence. Supported by R01 MH118308, we leveraged sleep EEG data from a population-
based cohort of children followed-up as adolescents with which we studied the age-related trajectories of slow
wave activity (SWA), sleep spindle density (SSD) and odds ratio product (ORP), three EEG biomarkers of sleep
intensity, integrity and depth, respectively. We showed that each followed distinct maturational trajectories,
differentially depending upon sex and pubertal development. In addition, we showed that, compared to typically
developing youth, those with unmedicated attention/learning disorders had a maturational disruption in SWA
during childhood and greater ORP levels in adolescence, while those with unmedicated internalizing disorders
showed a lower loss of frontal SWA in the transition to adolescence but greater ORP when medicated with
antidepressants. The lack of young adult data did not permit unveiling whether those developmental trajectories
were predictive of mental health outcomes at ages 20 to 30, a lifespan period critical for increased severity of
psychopathology. Federal research priorities include understanding the developmental trajectories of mental
health disorders across the lifespan and their underlying brain mechanisms. Hence, in this application, we
propose to study the association of SWA, SSD and ORP with young adult psychopathology by leveraging sleep
EEG data from the 15-year follow-up of a unique population-based child cohort, studied under our prior R01
MH118308 for their child (median 9y) and adolescent (median 16y) data and who are being recruited under R01
HL136587 for their young adult data (median 25y). We aim to leverage data from these subjects at age 20 years
or older and assessed for their sleep EEG and clinically-meaningful psychopathology outcomes. We will study
the longitudinal association between the trajectories of SWA, SSD and ORP with internalizing symptoms and
suicidality (Aim 1) and externalizing behaviors and working memory (Aim 2), and how these sleep EEG
trajectories may play a mechanistic role in the increased coexistence of internalizing and externalizing
psychopathology in young adulthood (Aim 3). Given the known sex differences in brain maturation, we will test
whether the associations in Aims 1-3 differ between males and females (Aim 4). This study will help better
understand the developmental trajectories of psychopathology as they relate to altered brain maturation and
sleep disruption at different life stages. Findings from this study will inform novel biomarkers for clinical trials that
aim at improving the pathophysiology and long-term prognosis of diverse forms of psychopathology across the
life span by targeting the sleeping brain.

Public health relevance
Project Narrative Sleep depth, intensity and integrity are important contributors to optimal health that, when disrupted, can escalate vulnerability to mood and behavioral problems in youth. We propose to study the impact of abnormal developmental trajectories of the sleeping brain with psychopathology in young adulthood by leveraging data from a 15-year longitudinal study of a unique cohort of children from the general population recruited for a prior R01. Findings from this study will inform novel biomarkers for clinical trials that aim at improving the pathophysiology and long-term prognosis of diverse forms of psychopathology across the life span by targeting the sleeping brain.